Investigating GSTP1 as a novel regulator of the cysteine redoxome in breast cancer and maker of vulnerability to redox-based therapy

Project Summary
Glutathione S-transferase Pi 1 (GSTP1) is an enzyme that conjugates glutathione to small
molecule electrophiles. GSTP1 has been implicated in promoting the growth of many cancer
types where GSTP1 overexpression is proposed to promote metabolic re-wiring or sequester
cancer-related signaling proteins through protein-protein interactions.
In contrast to the modest upregulation of GSTP1 in cancer reported by these studies, our
systematic evaluation of cancer cell lines, patient-derived xenografts, and patient tumors finds that
GSTP1 expression is uniquely and dramatically silenced by many orders of magnitude in luminal
breast cancer, going from one of the most abundant cellular proteins to barely express. Her2
positive (Her2+) breast cancers have a bimodal GSTP1 expression distribution, with a significant
proportion also silencing GSTP1.
Decreased GSTP1 expression in breast cancer allowed us to discover a novel, non-canonical
regulatory function of GSTP1: re-directing the flux of cysteine oxidation to structurally remodel the
proteome via allosteric disulfide bonds. These changes are critical for breast cancer
transformation since re-expression of GSTP1 and inhibition of redox signaling decreases the
transformation capacity of GSTP1-silenced breast cancer cells.
This proposal focuses on two Specific Aims. First, is GSTP1 silencing a therapeutic
vulnerability in BRCA? Second, what are the molecular and redoxomic consequences of GSTP1
silencing? Together, these Aims will provide new mechanistic insight into how GSTP1 expression
drives redox signaling in breast cancer and determine if GSTP1 silencing is a therapeutically
actionable vulnerability.

Public health relevance
Project Narrative GSTP1 is uniquely downregulated in luminal and some Her2-positive breast cancers. This proposal will explore whether epigenetic silencing of GSTP1 makes BRCA sensitivity redox-based therapy and delineate the molecular consequences of its repression.